Developmental Therapeutics (DT)

Members of the Developmental Therapeutics (DT) Program use breakthrough insights made at the Rogel
Cancer Center basic science programs to discover small molecule anticancer agents that can be advanced
into biomarker-driven clinical trials. The Program serves as the forum for investigators with shared interest in
identification and validation of new cancer-relevant targets and development of novel anti-cancer agents that
perturb epigenetic modifiers, block protein-protein interactions, inhibit kinase activities or induce degradation of
cancer-relevant protein targets. To further advances form the last period, DT Program research is focused on
one or more of the following Specific Aims: 1) validate novel cancer targets that are amenable to
pharmacologic intervention, 2) discover, optimize and evaluate promising therapeutic agents and potential
biomarkers of response in clinically relevant preclinical model systems, and 3) advance DT drug candidates
into clinical trials through structured collaborations with clinical investigator teams. The overarching goal of
program members is to generate critical preclinical proof-of-concept data for promising new cancer therapies in
a manner that will serve to guide clinical trial design and maximize translational impact.